The Johns Hopkins Clinical Research Scholars in Women's Health (BIRCWH)

Enter The overarching goal of the Johns Hopkins BIRCWH program (JH-BIRCWH) is to develop highly qualiﬁed, independent investigators who will conduct innovative and signiﬁcant women’s health and sex diﬀerences research. The program represents a successful and robust collaboration of the Johns Hopkins Schools of Medicine, Nursing, and Public Health. Since 2015 we have recruited 19 Scholars, all outstanding junior investigators from diverse disciplines. The success of the program is illustrated by their success: all have positions in universities primarily doing research in women’s health. Sixty nine percent have independent funding as PIs and 85% have peer reviewed research funding. Due to JH-BIRCWH mentorship and career development, these Scholars continue to develop as independent investigators and leaders in innovative, interdisciplinary research. Scholars broaden their understanding through the lens of a life course perspective with particular attention to research on the health needs of populations at high risk for poor health outcomes. During this next proposed period of support, our JH- BIRCWH program is well positioned for sustained success. Consistent with the Oﬃce of Research on Women’s Health (ORWH) strategic plan, we will continue to recruit and welcome highly motivated and qualiﬁed junior faculty scholars from the broad population. We will build on the established foundation of our learner-centered and competency-based approach to interdisciplinary career development. A critical resource for the JH-BIRCWH program is the cadre of highly experienced, internationally recognized faculty who are active in research related to women’s health or sex diﬀerences, and who are committed to supporting and sponsoring Scholars. The three core strength areas of the JH-BIRCWH program are: 1) diseases speciﬁc to women (e.g. women’s cancer and reproductive biology); 2) sex diﬀerences in disease expression (e.g. immunology, neuroscience, cardiovascular and genetics); and 3) social and cultural determinants of women’s health (e.g. violence against women, trauma, addictions and poverty). In this next proposed period of support, the JH-BIRCWH will annually support four scholars plus one or two additional scholars supported by institutional matching funds. Scholars will receive expert mentoring from a multidisciplinary team along with funding, and access to institutional resources. They will be well prepared to lead interdisciplinary teams to improve women’s health by advancing our understanding of sex diﬀerences and health concerns unique to, more prevalent, or with diﬀerential consequences in women.

Public health relevance
PROJECT NARRATIVE The Johns Hopkins BIRCWH program takes advantage of an extraordinary interdisciplinary academic environment to support the career development of promising junior scientists. Research will focus on diseases specific to women, sex differences in disease expression, the social determinants of women’s health, and sex disparities. Scholars will develop into independent investigators and leaders in interdisciplinary women’s health who improve clinical care for women and identify opportunities to more adequately address biological and social determinants of health.